MCSP TORFP NO. NIH-NINDS-20-02: MOURADIAN/DISNEY - BASE EC (PARKINSON'S)

The National Institute on Neurological Disorders and Stroke (NINDS) and the NIH Blueprint
Neurotherapeutics Network (BPN) have a need
for the Medicinal Chemistry Support Program (MCSP) to provide a full-service facility and staff who would
support a medicinal chemistry discovery program beginning at the Exploratory Chemistry phase to
develop structure activity relationship (SAR) analysis and design, synthesis, in vitro absorption,
distribution, metabolism, excretion and toxicology (ADMET), computational chemistry/Computer Aided
Drug Discovery (CADD) and compound logistics of storage and shipping to support the Contributor
Mouradian/Disney (Rutgers/Scripps) to develop a novel therapeutic effective in Parkinson’s. This will be
achieved by advancing the SAR/SPR of their small molecule heterocyclic starting compound utilizing their
assays and in vitro ADMET to identify novel, selective inhibitors of the target enzyme that are directed at
Parkinson’s. Our drug discovery approach will be to synthesize novel ligands based on the heterocyclic
scaffold that are potent inhibitors. Candidate molecules will undergo profiling to assess criteria
specifically related to the physicochemical properties of compounds in a therapeutic setting, including
enzyme selectivity and tests to determine potential interactions with key metabolic enzyme systems. The
goal is to advance the project to go/no go decisions and to progress to each of the Option phases in
succession (start of Hit-to-Lead and start of Lead Optimization). The data generated from this contract
will be used by NINDS, contributors or sponsored investigators in support of Investigational New Drug
(IND) application directed preclinical activities. The results of the efforts of this contract will be the basis to
advance preclinical candidate compounds for further development i.e., advanced PK and toxicological
evaluation in preparation of IND filings.